Genetic Analyses of Genes in Presenilin-Related Pathways

This proposal is aimed at continuing our ongoing efforts to identify and characterize novel AD genes involved in presenilin-related pathways. AD candidate genes implicated in presenilin-related pathways will be derived from three different pools: Pool 1. Positional candidate genes mapping to established AD genetic linkage peaks, including UBQLN1, VPS26A, VPS35, VDAC1, VDAC2, NCSTN, PSEN1 and TFCP2; Pool 2. Candidate genes derived from systematic meta-analyses performed on ourAlzGene.org database, including CHRNB2, DAPK1, SORCS1, SORL1, TNK1, HMGCS2, CH25H, and SOAT1; and 3. Novel AD candidate genes from our ongoing whole-genome association (WGA) screens of the NIMH AD family sample in which >1400 subjects from 457 uniformly ascertained and evaluated AD families have been genotyped using three different Affymetrix genotyping arrays: 500K genomic single nucleotide polymorphisms (SNPs), 100K genomic SNPs, and 20K coding SNPS (cSNPs). Follow-up analyses of presenilin pathway-related AD candidate genes will include genetic confirmation/replication testing, linkage disequilibrium analyses, and mutation identification. In collaboration with the other P01 projects and cores, we will also carry out biological and functional validation studies of specific candidate genes based on our genetic results. In specific aim 1, genotyping of the NIMH sample will be completed for all genes in all three pools. In specific aim 2, SNPs exhibiting genome-wide significance for family-based association with AD in the NIMH sample will be subjected to replication testing in four independent AD family samples: CAG (224 families; 505 subjects; AD: 245), NIA (353 families; 1117 DNAs; AD: 815), NCRAD (369 families; 1266 DNAs: AD: 895), and NIMH African American (24 families, 58 subjects; AD: 49). For genes exhibiting the strongest association with AD, we will carry out extensive linkage disequilibrium mapping of additional SNPs and re-sequencing in probands and unaffected individuals of specific associated families for each locus. In specific aim 3., we will perform bioinformatic (in silico) analyses of AD candidate genes to identify which SNPs represent potentially pathogenic gene mutations/variants for AD. Finally, in specific aim 4., we will collaborate with the other P01 projects and cores to carry out biological validation and functional analyses of novel AD candidate genes, including effects of RNAi silencing and overexpression of wild-type and potentially pathogenic mutations/variants on presenilin function, e.g. APP trafficking/processing as well as A(3 and AICD generation, y-secretase activity, APP-PS1 interaction, and PS1 conformation. Lay Summary: The four known AD genes (APP, PSEN1, PSEN2, and APOE) are the subjects of the vast majority of current biological research on AD. Yet, these genes represent only ~30% of the genetic variance of AD. The goal of this project is identify the additional AD genes implicated in presenilin-related biological pathways to increase our knowledge of the causes of AD and the role of the presenilins in AD pathogenesis.